Examining Gender as a Sociocultural Variable Shaping Health Outcomes of Cancer Caregiving

PROJECT SUMMARY/ABSTRACT
With advances in early detection and novel, targeted cancer treatments, a growing number of individuals
provide support for cancer survivors who have completed curative intent therapy (“curvivors”) as well as for
those who live for many years with metastatic disease (“metavivors”). Cancer caregiving relationships for
curvivors and metavivors alike are associated with high stress, particularly as individuals transition to post-
initial treatment survivorship and experience decreased contact with medical providers, continued need for
medical symptom monitoring, and evolution in relationship dynamics between caregiver and care recipient. As
such, caregivers (partners, family members, close friends) may struggle with unmet needs for their own well-
being and healthcare utilization (e.g., attendance at follow-up visits, routine healthcare screenings) while
supporting the survivor they care for. Though caregiving roles are disproportionately held by women, little is
known about possible gender differences in the health impact of cancer caregiving stress during the transition
to post-initial treatment survivorship. No existing interventions provide concurrent but separate support for
cancer survivors and caregivers at this critical transition point; as such, the parent R21 (“Building Resiliency
Among Caregivers of Curvivors and Metavivors: A Pilot Randomized Trial,” R21 CA273785-01) is highly novel
in its aim to evaluate the feasibility, acceptability, and preliminary efficacy of the Stress Management and
Resiliency Training-Relaxation Resiliency Response Program (SMART-3RP) as delivered concurrently to
separate groups of cancer caregivers and survivors. Building upon the aims of the parent grant, this
Administrative Supplement (in response to NOT-OD-22-030) will explicate key indices of feasibility and
acceptability by participant gender. Leveraging quantitative self-report and biobehavioral (i.e., hair cortisol)
data from 48 cancer caregiver-survivor dyads (N = 96), we will also analyze gender differences in baseline
characteristics mapping onto gender as a sociocultural variable (i.e., gender norms, gender-related traits, and
gender relations), as well as gender differences in preliminary efficacy of the SMART-3RP for caregivers’ and
survivors’ resiliency (primary) and healthcare utilization (secondary). To enrich interpretation of quantitative
analyses, we will add 3 questions to the planned qualitative exit interviews, regarding of sociocultural aspects
of gender in cancer caregiving. This Administrative Supplement will provide timely support for the research
team to meaningfully generate empirical mixed-methods data regarding gender differences in intervention
feasibility, acceptability, and preliminary efficacy and promote health equity for women in the growing
landscape of cancer caregiving research. Further, this work will provide a critical opportunity for MPIs Park and
El-Jawahri to support Dr. Lucy Finkelstein-Fox, a promising junior investigator mentored by Drs. Park and El-
Jawahri whose research program is dedicated to women’s health and intimacy in cancer survivorship.

Public health relevance
NARRATIVE There is a large and growing population of caregivers (partner/family member/friend) for cancer survivors, many of whom are women at risk of emotional distress and poor health outcomes. While the needs of cancer survivors and their caregivers are well described, few empirical studies consider gender as a sociocultural variable that may critically influence resiliency intervention feasibility, acceptability, and preliminary efficacy among heterogenous caregiving dyads. In response to NOSI NOT-OD-22-030 and aligned with goals outlined in the 2019-2023 Trans-NIH Strategic Plan for Women’s Health Research, we propose to examine gender differences in data collected for the parent R21 (“Building Resiliency Among Caregivers of Curvivors and Metavivors: A Pilot Randomized Trial,” R21 CA273785-01) and provide career development training to a junior investigator focused on women’s health and intimacy in cancer survivorship.